Endocrine Disruption of the Developing Dopamine System

PROJECT SUMMARY
Endocrine-disrupting chemicals (EDCs) affect a wide range of endocrine and neurobiological
functions. Animal models show causal relationships between exposure and adverse outcomes,
and epidemiological data in humans support correlations between EDC exposure and
neurobehavioral deficits. My proposal seeks to investigate the effects of perinatal EDC exposure
on the development of estrogen-sensitive neural midbrain dopamine (DA) circuits involved in
attentional and affective reward-processing behaviors. Here, I will test the hypothesis that
perinatal EDC exposure will lead to deficits in DAergic behaviors via disruption of estrogenic
signaling mechanisms that regulate cellular, molecular and epigenetic processes in the
developing brain DA system. Furthermore, gestational exposure affects both the fetus and
developing germ cells within the fetal gonad that become the sperm/ova leading to the F2
generation. Therefore, my work will focus on rats of both sexes in the F1 and F2 generations. To
do this, I will utilize a well-established EDC model of polychlorinated biphenyls using Aroclor 1221
(A1221), a weakly estrogenic mixture. Gestational exposure to A1221 perturbs neurobiological
development, and has latent effects on neuroendocrine functions, gene expression in the brain,
and behavior, in a sex-specific manner. However, its influence on attentional and affective reward-
processing behaviors is unknown; this is an important gap in knowledge. Effects of exposures will
be observed across two generations: F1 (exposed during gestation) and F2 (exposed as
developing germ cells). A primary outcome will be the display of attentional and affective reward-
processing behavioral outcomes during adulthood, as these behaviors are estrogen-sensitive and
associated with sex-biased mental health disorders in humans. Additionally, I will quantify
corresponding changes in the neuroanatomical organization of the brain’s dopamine system, and
expression of genes involved in estrogen and dopamine signaling. Because at least part of the
mechanism for brain organization is through actions of hormones on DNA methylation to
“program” how these genes function later in life, the research will also determine if epigenetic
changes (DNA methylation) are a mechanism for long-term changes in gene expression in
response to EDC exposure during critical developmental periods. These goals meet the NIEHS’
strategic goal to “investigate the effects of the environment on genome structure and function”,
including epigenetic regulation of biological processes, while including sex as a biological
variable. Moreover, the proposal extends our understanding of environmental influences on
behavioral and molecular endpoints relevant to cognitive and behavioral disorders in humans.

Public health relevance
PROJECT NARRATIVE Humans are ubiquitously exposed to endocrine-disrupting chemicals (EDCs) in the environment; among these, polychlorinated biphenyls (PCBs) strongly affect hormone-sensitive developmental processes and are associated with a wide-range of adverse neurobiological health outcomes in humans and wildlife. Understanding the underlying mechanisms of PCBs on neural development across generations, and how these exposures can alter future behavior, can inform medical interventions and guide public health policy. In my proposal a rat model of perinatal PCB exposure relevant to humans is used to explore the phenotype of neurobehavioral disorders and the molecular and epigenetic processes that underlie them in exposed individuals and their offspring.